Trial Master File Support Services for NIAID/DAIDS

Comprehensive and Rapid Response for NIAID Research Program (CARRRP): Provide the capacity and capability for a broad range of services necessary to support and conduct biomedical research in support of the NIAID mission and the management of activities specified under the Statement of Work and associated Task Orders. The purpose of this task order is to provide Trial Master File (TMF) technical expertise and TMF support services for NIAID Division of AIDS (DAIDS)-funded clinical trials in accordance with DAIDS approved Standard Operating Procedures (SOPs).